The Impact of Biological Age on Surgical Outcomes

PROJECT SUMMARY
Surgery is very common and risky for older adults. Nearly 25% of aging patients lose independence after
surgery, and 13% die within 1 year, 3x higher than expected mortality without surgery and 3x higher than
younger patients getting surgery. This trend is highly concerning for public health since the fraction of US
adults older than 65 years continues to grow and there is no standardized way to incorporate aging into risk
stratification for surgery. Despite the fact that chronological age (time since birth) is a known risk factor for
postoperative outcomes, it is an insufficient proxy for health in older adults. Restricting surgical care based
upon chronological age alone is imprecise and potentially harmful since it can exclude people who may benefit
from surgery. As an alternative, molecular estimates of age, termed “biological age”, provide a quantitative,
modifiable, and biologically-based estimate of health in older adults and are not simply a reflection of
underlying comorbidities. Biological age can even distinguish disease- and mortality-risk in people of the same
chronological age and comorbidities. Despite extensive evidence for the clinical impact of biological age, there
is a significant knowledge gap: we have no understanding of how biological age impacts surgical outcomes.
The proposed research aims to: (1) determine the effect of preoperative biological age on 1-year postop
mortality; and (2) evaluate preoperative biological age as a predictor of loss of independence after surgery.
This study will be conducted using the UKBiobank, a large prospective cohort study (N=502,649) that uniquely
integrates molecular, clinical, questionnaire, and mortality data, to investigate surgical risk related two
independent metrics of biological age relevant to surgical recovery – immunologic age and metabolic age. This
project will be the first to test the hypothesis that preoperative biological age is associated with various patient-
centered surgical outcomes, even when correcting for well-known medical, surgical, and sociodemographic
risk factors. The contribution of our project will be significant because it will give us a way to distinguish
biological risk for surgery in aging adults who are currently clinically indistinguishable. This will help guide
shared decision-making between patients and surgeons before surgery. The successful completion of this
project opens the door to targeting biological age with pharmacologic and non-pharmacological interventions to
improve postoperative outcomes.

Public health relevance
PROJECT NARRATIVE We propose to study how biological age affects surgical outcomes. This research is relevant for public health because the majority of surgeries are performed on older adults, and aging increases the risk of complications and mortality after surgery. This study will lay the foundation for using biological age to risk stratify older adults before surgery and for developing interventions that target biological age and improve outcomes after surgery.